Oil and Gas as Drivers of Climate Change and Health: Developing unique resources to investigate multi-level and diverse effects of exposure to oil and gas wells

PROJECT SUMMARY / ABSTRACT
The oil and gas industry generates half of all global greenhouse gasses. On the ground, local oil and gas
production creates myriad exposures that can increase risks of developing asthma and cancer, as well as liver,
immune, and neurologic diseases. Millions of California residents live, work, and play near active oil and gas
wells because the State does not require any minimum distance between those wells & schools, homes, parks,
or workplaces. Exposure to oil & gas wells is complex and dynamic, but few studies include the breadth and
depth of data necessary to fully assess contemporary health effects or understand future changes. The
California Teachers Study (CTS) is a prospective observational cohort that has followed N=133,477 adult
women, almost all of whom live in California, continuously since 1995-1996. We propose to create detailed,
individual-level data on CTS participants' exposure to oil and gas wells during CTS follow-up. First, we will use
detailed data on all oil and gas wells in California from the California Department of Conservation Geologic
Energy Management Division (CalGEM) well statewide tracking system (WellSTAR) and from Enverus, a
commercial service that maintains a national database of all oil and gas well drilling, system to identify who
was exposed to oil and gas well sites. We will create time-dependent exposure metrics that capture individuals'
exposures to active, idle, and capped wells, by time, distance, and production volume, as well as flaring
events. Second, we will integrate those exposures with other neighborhood-level measures of socioeconomic
status (from the US Census Bureau) and environment burden (from CalEnviroScreen). Third, we will
characterize the real-world exposure distribution of oil and gas wells and production over time and across CTS
participant subgroups of interest. These summary data and data visualizations will provide the specific and
detailed data researchers need to accelerate their planning and future research. We will also conduct a proof-
of-concept project by comparing respiratory-related emergency department visit patterns among participants
who were exposed vs. unexposed to oil and gas wells. The CTS is an ideal setting in which to generate these
novel data that can accelerate research on climate change. All of these data and resources will be openly
available to researchers everywhere via the secure, user-friendly, and cloud-based CTS Researcher Platform.
These data will enable a broad range of research that can quantify the effects of oil and gas production
exposure on numerous disease endpoints; evaluate the potential interactions between these exposures and
other aspects of the built and natural environment; and assess the potential impacts of past and future
changes in exposure, such as when well production is paused or permanently ended. These data will position
the CTS to support a broad range of hypothesis-driven population-sciences research on how oil and gas
production affects human health and influences the impact of climate change on human health.

Public health relevance
PROJECT NARRATIVE The significant increase in domestic oil production in the US over the last decade has also significantly increased the number of people who live close to and oil and gas wells, especially in California. Oil and gas production generates carcinogens, toxins, pollutants, and other harmful exposures, but the health effects on populations that live near oil and gas sites are not well understood. This project will generate detailed data on exposure to oil and gas wells in the California Teachers Study cohort, so that those data can be used to better characterize the real-world health effects of these exposures and better understand how potential future mitigation might impact human exposures and disease.